Community Engagement & Dissemination (CEDC)

Community Engagement and Dissemination Core Abstract
The Community Engagement and Dissemination Core (CEDC) plays a pivotal role in the PATC3H-IN network
by emphasizing community engagement and research dissemination as essential components of its mission.
This core defines community engagement as a dynamic, two-way exchange between researchers and various
key communities of interest within the six PATC3H-IN countries, encompassing adolescents and young adults
(AYA) living with or at risk for HIV, AYA researchers, family members (especially guardians) and friends of
AYA, HIV care providers, implementers, community members, and policy-makers. Building on a strong
commitment to enhancing the dissemination of AYA HIV research in low- and middle-income countries
(LMICs), the CEDC has a track record of successful participatory crowdsourcing activities aimed at promoting
AYA inclusion in HIV research. These initiatives involve collaborative problem-solving and sharing solutions
with the community, demonstrating the capacity to effectively engage AYA and disseminate research findings
through creative means such as infographics and short videos. The CEDC's overarching goal is to disseminate
evidence-based HIV interventions, research findings, guidelines, and programs to combat the HIV epidemic
among AYA using community-engaged participatory strategies. To achieve this, they propose three specific
aims. Aim 1 focuses on community engagement in network leadership. The CEDC plans to determine
engagement and dissemination plans for the PATC3H-IN network through crowdsourcing and a modified
Delphi method. The results of this process will lead to the development of a consensus statement on
engagement and dissemination strategies, with a focus on adaptability, scale-up, and sustainability. Aim 2
centers on outreach and training for communities. The CEDC aims to create a network-wide platform for
training communities, including PATC3H-IN researchers and AYA, in engagement and dissemination
strategies. This involves the development of tailored training modules, a practical guide, videos, support for
social media, and a consultation service. The training will leverage existing strengths within the network using
appreciative inquiry. Aim 3 involves the translation of science to service. The CEDC will evaluate community
engagement and dissemination strategies, tracking metrics and monitoring dissemination. Case studies will be
guided by the Translational Science Benefits Model, and a dissemination summit will provide a platform to
celebrate successes. The CEDC will establish the infrastructure needed to develop and maintain community-
driven engagement and dissemination plans for the PATC3H-IN network, enhancing the capacities of network
researchers to meet the needs of local communities for outreach and dissemination. The CEDC will contribute
unique value to community engagement and dissemination, ultimately helping to address the HIV epidemic
among AYA in LMICs.